Anticoagulation in Intracerebral Hemorrhage Survivors with Atrial Fibrillation and Imaging Features of Cerebral Amyloid Angiopathy and Small Vessel Disease

PROJECT SUMMARY
Non-traumatic intracerebral hemorrhage (ICH) is a devasting type of stroke caused by cerebral small vessel
disease (CSVD). One-fourth of ICH patients have atrial fibrillation (AF), an important risk factor for ischemic
stroke. Although anticoagulation therapy alleviates the risk of ischemic stroke in patients with AF, it can increase
the risk of ICH. Observational data including our own, indicate that among ICH survivors, CSVD features such
as microbleeds and white matter hyperintensities independently increase the risk of ischemic stroke, recurrent
ICH, and poor functional outcomes. Whether CSVD similarly influences the net clinical benefit of anticoagulation
in ICH survivors with AF represents a major knowledge gap. Therefore, the objective of this proposal is to
examine the heterogeneity of anticoagulation treatment effect by CSVD phenotype and develop risk stratification
tools to help guide anticoagulation therapy in ICH survivors with AF. Our central hypothesis is that
anticoagulation is associated neutral effect or harm in patients with cerebral amyloid angiopathy and with net
clinical benefit in patients with deep perforator arteriopathy. We will leverage prospective clinical and
neuroimaging data from 1900 patients enrolled in ASPIRE and ENRICH-AF, two clinical trials evaluating the
safety and efficacy of anticoagulation in ICH survivors with AF. Using baseline magnetic resonance imaging
scans, we will ascertain individual CSVD features and adjudicate CSVD phenotypes. Aim 1 will evaluate if the
four validated CSVD phenotypes (cerebral amyloid angiopathy, deep perforator arteriopathy, mixed, and
undetermined) modify and mediate the association between anticoagulation and the outcomes of recurrent ICH
(1A), major hemorrhage (1B), net clinical benefit of any stroke (1C), and good functional outcome defined by a
modified Rankin score of 0-2 (1D). Aim 2 will develop a risk-stratification score for recurrent ICH using CSVD,
demographic and clinical data from ENRICH-AF, which will then be tested in ASPIRE as an effect modifier of the
association of anticoagulation therapy with recurrent ICH (2A), major hemorrhage (2B), net clinical benefit (2C),
and good functional outcome (2D). Aim 3 will leverage deep learning models to develop and validate automated
tools for the ascertainment of CSVD phenotypes, and subsequently evaluate if these automatically determined
CSVD phenotypes modify the association of anticoagulation with recurrent ICH (3A), major hemorrhage (3B),
net benefit (3C), and functional outcome (3D). This automated image analysis pipeline will be trained in ENRICH-
AF and externally validated in ASPIRE. Impact: Regardless of the direction of the parent trials, successful
completion of these aims will help identify subpopulations of ICH patients with AF who may experience benefit
or harm from anticoagulation, taking the field one step closer to personalized medicine. The proposed research
will have important multiplicative effects by generating new research and clinical tools, including a novel risk-
stratification score, automated CSVD quantification tools, and the largest harmonized dataset of clinical trials
evaluating anticoagulation in ICH survivors with AF assembled to date.

Public health relevance
PROJECT NARRATIVE Patients who survive an intracerebral hemorrhage and have co-existing atrial fibrillation, face a high risk of ischemic and hemorrhagic stroke, which can hamper recovery. This proposal seeks to use brain imaging to guide the use of anticoagulant therapy in this high-risk patient population with the ultimate goal of preventing recurrent stroke, reducing disability, and improving survival.